Inflammation and Hepatocellular Carcinoma: A Multiomics Approach to Improve Early Detection, Causal Inference, and Lifestyle Based Prevention

PROJECT SUMMARY/ABSTRACT
Dr. Xinyuan (Cindy) Zhang’s long-term goal is to become an independent and active researcher in the field of
cancer molecular epidemiology that contributes to the development of novel strategies for cancer prevention
and early diagnosis. Hepatocellular carcinoma (HCC) is highly lethal, without an effective early detection
method. Chronic inflammation has been observed in HCC, but neither the genomics nor proteomics signatures
of inflammation have been examined in the context of HCC etiology or lifestyle-based prevention. Leveraging
the wealth of resources from eight population-based prospective cohorts, Dr. Zhang will integrate molecular
data into epidemiology studies to address gaps in understanding HCC risk and improving risk assessment. In
Aim 1, Dr. Zhang will use computational biology and system biology skills to examine pre-diagnostic plasma
proteomics of incident HCC cases compared to matched non-HCC controls. She will use machine learning
methods to develop and validate Inflammatory Proteomics Signatures for HCC early detection. In Aim 2, Dr.
Zhang will analyze genomics and proteomics data by mapping inflammatory protein quantitative trait loci and
performing Mendelian Randomization analysis for HCC risk. Findings on inflammatory proteomics and
genomics will be further compared against current tests in a clinical cohort of liver cirrhosis patients who are
currently undergoing HCC screening. In Aim 3, Dr. Zhang will develop a hypothesis-driven empirically derived
Anti-Inflammatory Lifestyle Score by regressing health behaviors and factors against inflammatory multiomics
markers. In preliminary studies, Dr. Zhang has shown that a dietary score weighted by traditional inflammation
markers was associated with HCC risk and has identified a protein biomarker model for HCC prediction,
suggesting that further improvement in predictive performance is feasible. Successful completion of the novel
research aims will be supported by a well-tailored training plan with three specific objectives in (1) advanced
multiomics analytics, (2) cancer biomarkers, and (3) molecular epidemiology study design and management.
The outstanding mentoring team with complementary expertise, rigorous training activities, and rich resources
will equip Dr. Zhang with the knowledge, skills, and data necessary for research success and transition to
independence under this NCI Early K99/R00 award.

Public health relevance
PROJECT NARRATIVE To address the current challenges for hepatocellular carcinoma (HCC), a cancer with rising incidence and high mortality rate associated with diagnosis commonly at a late stage, Dr. Xinyuan (Cindy) Zhang proposes to integrate proteomics and genomics data from multiple cohorts and patient registries to identify novel biomarkers that can be used to identify HCC in its early stage and also can refine our understanding of biological pathways linking chronic inflammation to HCC. Further, she proposes to integrate these biomarkers with epidemiological data to develop an anti-inflammatory lifestyle associated with subsequently lower HCC risk. This innovative project will form the basis for HCC early detection, mechanism inference, and lifestyle- based prevention strategies, and will extend Dr. Zhang in an interdisciplinary direction with new skills and data to launch her independent career.